Three-Dimensional Spatio-Temporal Control of Lipid Nanoparticle Manufacturing for Improved Nucleic Acid Delivery

PROJECT SUMMARY
The COVID-19 pandemic has established the importance of nucleic acid-based lipid nanoparticles (LNPs)
for the future of global health. The benefits of lipid nanoparticles are multifaceted as they protect sensitive
pharmaceutical payloads from enzymatic degradation and allow for the modification of solubility, release
kinetics, and bioavailability. While chemical formulation of LNPs has been widely explored, the effects of
manufacturing—specifically microfluidics processing—are not currently well-understood. This knowledge
gap presents challenges in the production of intricate nanoparticle structures, which require specialized
microfluidic systems that produce well-defined and reproducible flow configurations. The proposed
research focuses on developing 3D-printed channel architectures to precisely control LNP structure and
properties to enhance transfection efficiency without modifying their chemical composition. Aim 1 involves
designing, simulating, and testing various 3D channel architectures to manipulate flow conditions and tailor
LNP properties. Aim 2 focuses on structural determination via SAXS and CryoTEM, and assesses the
impact of LNP structures on mRNA transfection efficiency through in vitro transfection studies. Aim 3 will
demonstrate the therapeutic- and disease-agnostic design workflow by robustly encapsulating siRNA and
pDNA. This project aims to overcome the limitations of current LNP manufacturing methods which are
constrained by fixed geometries and limited control over LNP assembly processes. Development of our
enabling technology will offer an additional process parameter - channel architecture, for tuning LNP
properties and structure in a rapid and customizable manner that is broadly applicable.

Public health relevance
PROJECT NARRATIVE Lipid nanoparticle (LNP) carriers have allowed the robust delivery and expression of nucleic acids (NA), with the most notable being the COVID-19 mRNA LNP vaccines. However, current LNP manufacturing methods are limited to either pipette mixing or 2D microfluidic chips, the former which does not allow for any precise control over fluid interactions, and the latter being limited by fixed channel architecture, long and expensive microfabrication, single-use devices that clog, and very little control over fluidic interactions beyond tuning of flow rates. We aim to accelerate the NA therapeutic development pipeline by leveraging therapeutic- and disease-agnostic 3D printed fluidic devices that allow for precise spatiotemporal control over fluidic interfaces, resulting in higher-quality LNPs with enhanced NA delivery.